The Role of Retroelements in Centromere Function

Project Summary
With the completion of the Human Genome via the Telomere-to-Telomere Consortium, a
complete characterization of the centromeric, pericentromeric, and telomeric regions of every
chromosome, including the repeats (satellite remnants, transposable elements (TEs), retroviral
insertions, etc.) is conceivable. Although it is widely accepted that centromeres are essential and
necessary for proper chromosome segregation during cell division, there is a significant lack in
fully understanding centromere dynamics. The limitations of previous technology are at the core
of this knowledge gap in centromere entology. Current advances in sequencing and
bioinformatic techniques provide an effective means to characterize and identify heterochromatic
regions of the genome. Previous studies uncovered centromeric regions as more than long
tandem arrays of higher order satellite repeats (HORs) that are comprised of transcriptionally
active retroelement insertions displaying that repeat and retroelement transcription is necessary
to identify topologically associating domains (TADs), understand the influences on 3D genome
structure, and the modulation of activity of genes. We propose to determine how centromere
transposable element (cenTEs) sequences influence centromeric function, and thus genome
integrity in humans. This project provides a comprehensive analysis of the centromere landscape
by studying three objectives. One, determine whether cenTEs are required transcription
initiators in centromere assembly by delineating sites of transcription, and testing the impact of
transcription initiation on assembly. Two, explain whether cenTEs are epigenetic drivers of
centromere chromatin assembly by determining post-transcriptional localization of cenTE RNAs,
test the impact of transcripts on centromere assembly, and describe cenTE mobile activity. And
three, this study explains whether cenTEs are required for pre-and post- centromere stabilization
by utilizing human artificial chromosome assays and long read sequencing. These findings will
provide a novel understanding of centromere function and fitness. A comprehensive study such
as this is paramount to understanding the complexities of human diseases such as cancer. This
current technological golden age enables researchers to ask new questions to old problems
utilizing creative techniques.

Public health relevance
Project Narrative Centromeres are the primary constriction sites on each human chromosome and are essential to the proper segregation of genetic material into each daughter cell during mitotic and meiotic cell division. Improper segregation of chromosomes caused by a centromere defect leads to a myriad of human pathologies, such as infertility and cancer. This work aims to study the complex nature of human centromeres and reveal the network of operational elements, such as retroelements and transcription, that are necessary for chromosome stability.